Spreading the Integrated District Evidence-to-Action Program for Neonatal Mortality Reduction (IDEAs) in Mozambique

NICHD Supplemental Program: Administrative Supplements to Promote Diversity in Health-Related Research Program: NICHD Supplemental Program Parent Project: Spreading the Integrated District Evidence-to-Action Program for Neonatal Mortality Reduction (IDEAs) in Mozambique (5R01HD092449-03) Project Summary/Abstract According to the Global Burden of Disease 2016 Healthcare Access and Quality analysis, large geographical inequalities in healthcare access and quality persist across and within countries. The Lancet Global Health Commission on High Quality Health Systems in the Sustainable Development Goals (SDG) Era found that Poor-quality health systems result in more than 8 million deaths per year in Low and Middle-Income Countries (LMICs), resulting in economic welfare losses of $6 trillion US dollars. Improved understanding of locations and quality of services can address gaps. The overall goal of this Research Supplement to Promote Diversity in Health-Related research is to contribute to the scientific community by introducing geospatial analysis methods in implementation science research by demonstrating the feasibility of integrating Geographic Information System (GIS) methods to enhance evaluation of audit and feedback strategies. Specifically, this study will inform the evaluation of district-based dissemination and implementation strategy for the Integrated District Evidence-to-Action Program for Neonatal Mortality Reduction (IDEAs) by providing a spatial lens in the evaluation of the program’s reach and effectiveness. The results from this research will help identify modifiable barriers to health care seeking of pregnant and postpartum women, and their children. Access is defined in terms of client’s travel time from place of residence to a primary health care with quality Antenatal Care (ANC) and institutional delivery by skilled attendance. Our team will apply a bi-directional systems evaluation approach that considers both the supply (service provider) and demand (clients) perspectives.

Public health relevance
NICHD Supplemental Program: Administrative Supplements to Promote Diversity in Health-Related Research Program: NICHD Supplemental Program Parent Project: Spreading the Integrated District Evidence-to-Action Program for Neonatal Mortality Reduction (IDEAs) in Mozambique (5R01HD092449-03) Project Narrative Despite dramatic reductions in under five mortality globally, continued high neonatal mortality (deaths in the first 28 days of life) have stagnated further advancements. Improving coverage and quality of available evidence-based interventions delivered at or around the time of birth could jump start these mortality reductions. This Supplement to Promote Diversity in Health-Related Research integrates geographic information system (GIS) techniques into an ongoing evaluation of an audit and feedback intervention in Mozambique. The research will utilize data collected by parent project to investigate determinants of physical access to primary health care, and incorporates a career development plan for Jeremiah (Ermyas) Birru (pre- doctoral PhD student at the University of Washington’s implementation science program).